Extracellular vesicles released in response to Yersinia pestis

SUMMARY
Extracellular vesicles (EVs) are membrane-bound vesicles released by cells that are potent vehicles
for intercellular communication. The signaling capacity of EVs is mediated by incorporation of different
biomolecules (e.g. proteins, lipids, nucleic acids, and carbohydrates) within individual vesicles.
Neutrophils produce EVs upon recognition of a variety of stimuli, but the biological properties of EVs
change depending on the stimuli encountered. Thus, depending on stimulation, neutrophil-derived EVs
have been shown to induce both pro- and anti-inflammatory responses in recipient cells. Neutrophils
can also produce a subset of EVs that are directly microbiostatic to bacteria and fungi. However, the
EV response by neutrophils has only been characterized for very few bacterial species, and therefore,
we have a limited understanding of the full potential of neutrophil-derived EVs in response to different
bacterial infections. Yersinia pestis is the causative agent of the human disease known as plague. Y.
pestis evades immune cell recognition via direct interactions with innate immune cells that disrupt the
normal responses by these cells. Specifically, Y. pestis uses a type three secretion system (T3SS) to
directly secrete bacterial proteins (called Yops) into host cells, which disrupt specific host cell signaling
pathways. The outcomes of Yop translocation into host neutrophils include: blocking phagocytosis,
inhibition of the generation of reactive oxygen species, and decreased production of pro-inflammatory
cytokines by neutrophils. Recently, we and others have shown that Y. pestis is able to block neutrophil
granule exocytosis in a T3SS-dependent manner. Together, these data show that Y. pestis efficiently
alters endocytic and exocytic activities by neutrophils. Despite its ability to disrupt endocytic and
exocytic pathways, the ability of Y. pestis to alter the production of EVs by host cells has not been
previously investigated. With a growing appreciation for EVs in inflammation and bacterial clearance,
our lack of a proper understanding of the EVs released by innate immune cells in response to Y. pestis
represents a critical knowledge gap in the immune response to Y. pestis. Based on previously published
studies and our preliminary data, we hypothesize that Y. pestis actively alters the production of EVs by
innate immune cells, and that this alteration has a direct impact on how EVs can influence the immune
response to the bacterium. To test this hypothesis, in Aim 1 we will define the composition of the
payloads packaged into EVs by neutrophils in response to Y. pestis infection and whether the T3SS
and Yop effectors alter the production of EVs. In Aim 2, we will determine the impact of EVs isolated
from neutrophils infected with Y. pestis or a Y. pestis strain lacking the Yop effectors on immune cell
response to Y. pestis infection. Completion of these Aims will provide for the first time a comprehensive
description of the EVs produced by human neutrophils in response to infection with Y. pestis.

Public health relevance
PROJECT NARRATIVE Extracellular vesicles (EVs) are released by cells to mediate cell-to-cell communication and contribute to establishing the proper immune response during infection. Our goal is to define how Yersinia pestis, the causative agent of plague, alters EV production by immune cells to disrupt cell communication and inhibit the recruitment of immune cells to the site of infection (referred to as inflammation). Because inducing inflammation during early stages of plague can improve the therapeutic window for a patient, defining mechanisms used by Y. pestis to inhibit inflammation is not only important for our understanding the pathogenesis of this bacterium, but will help us to identify new approaches to improve current plague therapy.